Community Engagement Core

ABSTRACT- COMMUNITY ENGAGEMENT CORE:
To foster relationships between the CHHE and communities in North Carolina, the Community Engagement
Core (CEC) will lead efforts on collaborative dialogue among researchers, educators, and citizens. Particular
attention will be given to deepening established relationships and forging new partnerships with vulnerable
communities throughout the eastern portion of the state, with a specific focus on our partner communities in
Durham, Raleigh, and Wilmington. We envision an inclusive and comprehensive approach to our engagement
efforts. The CEC will (1) exchange important information with vulnerable groups and our target audiences (to
raise awareness of environmental health issues and increase environmental health literacy), (2) gather
concerns and suggestions on environmental exposures faced by our partner communities in their everyday
lives, and (3) forge new paths in encouraging researchers and residents to work together as equal partners to
further environmental health knowledge and solve local problems through environmental health science.
Within CHHE, the CEC will link the Facility Cores, Research Interest Groups, and Center leadership. CEC-
sponsored activities will include colloquia and an annual summit that helps Center researchers better
appreciate the social and cultural impact of their work for communities that benefit from it. Going beyond a
purely translation-based approach that featured highly in the first funding cycle, we intend to broaden and
sharpen the scope of who takes part in our engagement efforts, what environmental health communication
and education looks like, how engagement unfolds appropriately and effectively, and why we embrace an
inclusive engagement approach, which will translate into engaged scholarship to share our insights with
researchers and practitioners.